Novel mechanism of neural and muscular degeneration

Ant1 is the muscle/heart/central nervous system (CNS) isoform of adenine nucleotide translocase that is
primarily involved in ATP/ADP exchange across the inner mitochondrial membrane (IMM). An increasing
number of missense mutations in Ant1 are found to cause dominant diseases that affect skeletal muscle and
the central nervous system. These diseases are commonly manifested by fractional mtDNA deletions and mild
bioenergetic defects. The mechanism of neuromuscular damage in the diseases is poorly understood.
Interestingly, our recent studies in yeast and cultured human cells suggested that the mutant Ant1 is misfolded.
This leads to cell death by a novel mechanism that we named mitochondrial Precursor Overaccumulation
Stress (mPOS). mPOS is characterized by the toxic accumulation and aggregation of un-imported
mitochondrial preproteins in the cytosol. These findings led to the central hypothesis that the mutant Ant1
primarily affects mitochondrial protein import. This results in mPOS in the cytosol, which plays an important
role in inducing neural and muscular degeneration. Fractional mtDNA deletions occur independent of
nucleotide transport activity, likely as a secondary damage collateral to reduced mitochondrial protein import.
In this application, we propose to directly test this hypothesis in mouse models. We successfully generated
knock-in (KI) mouse lines expressing misfolded variants of Ant1. Preliminary studies indicated that these mice
develop phenotypes consistent with neural and muscular degeneration. In Specific Aim 1, we will use these
unique experimental models to test the hypothesis that misfolded Ant1 induces neural and muscular
degeneration and mtDNA instability independent of nucleotide transport. In Specific Aim 2, we will use various
experimental tools that we developed in yeast, cultured human cells and the Ant1-KI mice to test the
hypothesis that the misfolded Ant1 (or Aac2 in yeast) causes structural and functional damage to the
mitochondrial protein import machinery and induces mPOS in the cytosol. In Specific Aim 3, we will determine
the mechanisms that protect cells against Ant1-induced protein import stress and mPOS. Success of the
project will establish a mouse model of protein import stress associated with mPOS. Particularly, validation of
the mPOS model would help reconciling the mitochondrial and proteostatic pathways in many neural and
muscular degenerative diseases. Finally, the results could have important implications for the understanding
and therapy of Ant1-induced diseases, as well as many other clinical conditions that directly or indirectly affect
mitochondrial protein import.

Public health relevance
An increasing number of dominant mutations are found in adenine nucleotide translocase 1 (Ant1) to cause multi-systemic neural and muscular degeneration, but the underlying mechanism is poorly understood. We generated mouse models to test the hypothesis that the pathogenic variants of Ant1 affect mitochondrial protein import and cause mitochondrial Precursor Over- accumulation Stress (mPOS) in the cytosol. The studies may uncover protein import stress and mPOS as novel mechanisms of neural and muscular degeneration, and help the understanding and treatment of Ant1-induced diseases and possibly, many other clinical conditions that directly or indirectly affect mitochondrial protein import.